Characterization and restoration of exhausted immune responses in humanized Bone marrow-liver-thymus (BLT) mice infected with HIV-1

? DESCRIPTION (provided by applicant): Cellular immune responses play a crucial role in controlling viral replication in HIV- infected individuals. However, HIV virus adopts numerous mechanisms to evade the immune system and the host ultimately fails to control the viral replication leading to development of AIDS. Chronic inflammation and ongoing viral replication may lead to immune exhaustion, which is characterized by poor anti-viral responses against HIV. The major aims of the proposal are to 1) characterize the mechanisms of immune dysfunction and exhaustion during chronic HIV infection and 2) explore various strategies to restore or prevent immune exhaustion and improve viral control using the humanized mice model. The strategies include 1) targeting activation inhibitory molecules Tim-3 and PD-1 signaling by antibody blockade or shRNA knock down; and 2) targeting persistent type I IFN signaling to reduce the production of immunosuppressive factors that contribute to immune exhaustion. This study will identify underlying mechanisms for T cell exhaustion and provide key information for future immune based therapies aimed at treating chronic HIV infection.

Public health relevance
PUBLIC HEALTH RELEVANCE: Current therapies to stop virus replication in the body are expensive and can have side effects and do not eliminate the virus from the body. We will explore a therapeutic approach designed to engineer a patient's immune system so that it can directly kill cells infected by HIV, thereby preventing spread of the virus throughout the body, decreasing virus replication, and perhaps eliminating HIV from the body. This will synergize with the other proposals in this Program in hopes of preventing the HIV-induced destruction of the immune system, restoring the body's ability to mount immune responses against a variety of infectious agents and cancers, and potentially eliminating the need for the patient to take antiretroviral drugs.